OBESITY IN BLACK WOMEN PREDICTORS OF SUSCEPTIBILITY TO OBESITY #5

The specific aim of this study is to test the following hypothesis: that black women, as compared to white women, have greater prediposing factors which contribute to the development of obesity.